Worry now or wait: A mixed-methods study of caregivers' and pediatricians’ decision-making for late talking

PROJECT SUMMARY/ABSTRACT
The long-term objective of this line of research is alleviate information and knowledge-to-practice gaps
related to late talking for caregivers and pediatricians. This work supports NIDCD’s mission of reducing the
burden of communication disorders, and specifically the Tackling Acquisition of Language in Kids (TALK)
initiative goals to better understand information and practice needs related to late talking for caregivers and
pediatricians. Late talking occurs in approximately 10-20% of all toddlers. Upwards of half of late talkers later
have largely typical language functioning. Predicting which late talkers go on to develop neurodevelopmental
disorders is imprecise despite decades of research. Therefore, making screening, evaluation, and intervention
decisions for late talkers is difficult. For many late talkers, their caregivers’ first decision point comes at well-child
visits with their pediatricians. The prognostic uncertainty of late talkers introduces a major dilemma for these
invested parties: should we worry now or should we wait? How caregivers and service providers, specifically
pediatricians, arrive at an answer to this question is largely unknown. We address three current barriers: (a) we
do not know what caregivers of late talkers need to know to effectively participate in the decision-making process,
(b) we do not know what pediatricians of late talkers need to know to effectively lead the decision-making
process, and (c) we do not know how social determinants of health uniquely affect knowledge and decision-
making gaps about late talking. Our inquiry is rooted in the Bioecological Model of Human Development to
identify information barriers and facilitators to decision making by caregivers and pediatricians. Across three
aims we use a mixed methods approach to ascertain (a) current methods that caregivers and pediatricians use
to obtain information to support decision making about late talking, including barriers and facilitators to obtaining
diagnosis and services, (b) information needs that caregivers and pediatricians believe are vital to support their
decision making about late talking, and (c) whether these information needs differ across families from different
backgrounds. We use an Exploratory Sequential Design to address the aims. First, in Aims 1 and 2 we use
qualitative methods to ascertain information needs and practice gaps across two invested parties: caregivers of
late talkers and the pediatricians who serve them. Then, we integrate the results from Aims 1 and 2 with the prior
literature to develop quantitative measures to use in a nationwide sample of 350 caregivers of late talkers to
identify social determinants of health that impact information and practice needs about late talking. This study
will provide a better understanding about how caregivers and pediatricians access and use information to make
decisions about late talking, as well as how social determinants of health impact information and practice needs
of families. Including diverse perspectives across caregivers and pediatricians will lead to increased
understanding of the impact of social determinants of health on decision making related to late talking in the
short-term and contribute to the development of culturally-relevant counselling materials in the long-term.

Public health relevance
PROJECT NARRATIVE Late talking occurs in approximately 10-20% of all toddlers; however, upwards of half of late talkers go on to have largely typical language functioning. Predicting which late talkers go on to develop neurodevelopmental disorders is imprecise despite decades of research; therefore, making screening, evaluation, and intervention decisions for late talkers is difficult for caregivers and pediatricians. The proposed research is relevant to public health and NIDCD’s mission to improve the lives of individuals with communication disorders, and specifically the Tackling Acquisition of Language in Kids (TALK) initiative that seeks to better understand early language delay, because it contributes to our understanding of how caregivers and pediatricians decide whether to worry now or wait about late talking, including how they access information and use it to make decisions.